HEPARIN METABOLISM IN NEWBORN

Pharmacokinetics of intravenous heparin will be studied in newborn infants of various ages. Both clotting and chromogenic assays for heparin and AT-III heparin cofactor will be used.